Building on our Success as the NOPREN Coordinating Center

Project Summary
CDC’s Nutrition and Obesity Policy Research and Evaluation Network (NOPREN) aims to inform policies and
practices designed to support the equitable intake of healthy, nutritious foods so that everyone has a fair
chance at health. Over the prior 10 years, the Coordinating Center at University of California San Francisco
(UCSF) has built NOPREN into the nation’s premier platform for the collaborative translation and dissemination
of nutrition and obesity policy research. We have grown network membership from >100 in 2014 to >3,000,
with representatives from professional organizations, academic institutions, federal agencies, and state and
local health departments; hosted >100 monthly State-of-Science webinars, with a tripling of attendance to an
average of 150-200 attendees; supported triple the original number of NOPREN Work Groups, who have
developed, published, and disseminated dozens of manuscripts, tools, resources, and policy briefs; and
created a robust suite of professional development and networking opportunities for students and early career
professionals. Our network evaluation indicates that NOPREN engagement leads to tangible products and
deliverables, in addition to the less quantifiable connections that help accelerate research and evaluation and
create opportunities for collaboration among researchers siloed across the country. In order to build on this
success, we propose five additional years of coordination which will focus on the following Aims: (1) increasing
the field’s capacity to conduct high-quality, transdisciplinary policy research that accelerates implementation of
CDC Division of Nutrition, Physical Activity, and Obesity (DNPAO) nutrition and obesity-prevention strategies;
(2) disseminating research findings to internal, external, and non-traditional, inter-disciplinary partners through
varied communication strategies; and (3) enhancing coordination and engagement among public health
practitioners, organizational implementers, and academic nutrition and obesity researchers. Our
implementation and evaluation efforts will be guided by CDC’s Science Impact Framework.
We will also conduct an implementation project aligned with the goals of NOPREN and DNPAO. This mixed-
methods evaluation of implementation of the HER Nutrition Guidelines in food banks across the US will be
guided by the Consolidated Framework for Implementation Research. We will interview representatives at food
banks with high and low success implementing the HER Guidelines to assess barriers and facilitators, use that
information to create a quantitative measure assessing implementation across multiple dimensions, and then
administer that tool to all Feeding America food banks.

Public health relevance
Project Narrative CDC’s Nutrition and Obesity Policy Research and Evaluation Network (NOPREN) is the nation’s premier platform for the collaborative translation and dissemination of nutrition policy, systems, and environmental (PSE) research. We will continue our highly successful leadership of NOPREN’s Coordinating Center for another five years in order to expand its reach and impact, which we will achieve by increasing the field’s capacity to conduct high-quality transdisciplinary research that accelerates implementation of DNPAO’s nutrition and obesity-prevention strategies; disseminating research findings to internal, external, and non- traditional, interdisciplinary partners; and enhancing coordination and engagement of multi-disciplinary partners. In support of DNPAO’s Food Service and Nutrition Guideline PSE strategy and NOPREN’s goals, we will also use an implementation science approach to develop and deploy a measurement tool supporting dissemination of nutrition guidelines in charitable food settings.